The Role of FKBP10 in Recessive Osteogenesis Imperfecta

Osteogenesis Imperfecta (OI) is the most commonly inherited form of brittle bone disease and displays a spectrum of severity from mild phenotypes to severe early lethality. Key clinical features of OI are bone fragility and low bone mass, whereas patients may also display blue sclera, dentinogenesis imperfecta, joint and skin laxity, hearing impairment and/or wormian bones on the skull [1]. Specifically, this fellowship focuses on a gene in which mutations result in recessive OI as well as Bruck Syndrome termed FK506 Binding Protein 10 (FKBP10) that encodes the FKBP65 protein [2, 3]. The FKBP65 protein complexes with Heat Shock Protein 47 (HSP47) and together they are thought to be involved in chaperoning of collagen in the endoplasmic reticulum [4, 5]. Currently, we do not understand the consequences of FKBP10 loss and its role in collagen and ECM formation. Therefore our goal is to elucidate the role of FKBP10 in the skeleton and how null mutations lead to progressively deforming OI. In other types of recessive OI, the biochemical modifications of collagen are altered, in particular by the complex of proteins consisting of Prolyl-3-Hydroxylase-1 (P3H1), Cartilage Associated Protein (CRTAP) and prolyl cis-trans isomerase cyclophilin-B (PPIB) [6]. Preliminary data concerning the Crtap knockout mice also suggests that there may be cell signaling defects in these mice. In addition, in vitro studies of human cells with FKPB10 loss show ER stress, fragmented Golgi, procollagen aggregates, and increased numbers of autophagosomes. This suggests that there may be strong cellular phenotypes and the unfolded protein response pathway may be affected. We hypothesize that due to changes in intracellular conditions owing to Fkbp10 loss, disruptions in cellular and possibly biochemical phenotypes lead to common mechanisms that may exist between different causes of OI due to the similarity in phenotypes. We aim to test this hypothesis by determining the in vivo phenotypes of FKBP10 loss on skeletal and connective tissues, assessing the biochemical and cellular phenotypes of Fkbp10 null cells, and evaluating cell signaling defects in the absence of Fkbp10. This research is important for establishing common mechanisms of disease which may provide potential therapeutic targets for patients with OI and Bruck syndrome, especially through addressing altered cell signaling and altered collagen biochemistry which may affect it. The National Institute of Dental and Craniofacial Research is the recipient organization of this fellowship because OI and Bruck syndrome are characterized by craniofacial phenotypes.

Public health relevance
This project serves to elucidate the role of the loss of the gene FK506 Binding Protein 10 (FKBP10) which encodes the protein FKBP65 and complexes with Heat Shock Protein 47 (HSP47) in order to chaperone collagen in the extracellular matrix. This loss results in Bruck syndrome and progressively deforming recessive Osteogenesis Imperfecta (OI), a form of brittle bone disease. Through this research we hope to discover novel mechanisms of OI and commonalities that exist between various causes of OI, potentially leading to new targets for therapeutics.